Hypoglycemia and alpha cell regulation

Project Summary/Abstract Understanding the interplay between pancreatic [unreadable]- and [unreadable]-cells that exerts local control on glucagon secretion is the focus of this application. Blood glucose levels are controlled primarily by two hormones, insulin, which governs tissue uptake and utilization of glucose and inhibits glucose production by the liver, and glucagon, which counteracts the inhibitory action of insulin on hepatic glucose production. Diabetes is a bi-hormonal disorder and impaired [unreadable]-cell function, in the context of insulin deficiency or insulin resistance, contributes to the hyperglycemia that is the hallmark of the disease. In type 1 diabetes, the major clinical consequence of defective glucagon secretion is insulin-induced hypoglycemia and fear of hypoglycemia is the main limitation to achieving good glycemic control and thus preventing the secondary complications of hyperglycemia. Considerable clinical evidence shows that elevated glucagon, secondary to altered [unreadable]-cell function, contributes to postprandial hyperglycemia in type 2 diabetes. Glucagon secretion can be suppressed by [unreadable]-cell secretory products and paracrine control of [unreadable]-cell function, the intra-islet insulin hypothesis, is well documented. Using a high-to-low glucose switch-off protocol we have shown that Zn2+, co-secreted with insulin, can suppress glucagon secretion during hypoglycemia and we have hypothesized that KATP channels that modulate Ca2+ signaling may be a target for Zn2+. Hyperglycemia can also suppress [unreadable]-cell secretion potentially via a KATP channel dependent action on Ca2+ signaling. Amino acids are known to stimulate glucagon secretion via both metabolic and electrogenic effects, but the interplay between glucose and physiologic levels of amino acids is not well understood and the identity of amino acid transporters in [unreadable]-cells is rudimentary. Glucagon secretion is potently stimulated by epinephrine and norepinephrine, but the relative importance of local control of [unreadable]-cell function vs their response(s) to hypothalamic and other CNS inputs remains controversial. Our specific aims are to: Specific Aim #1. Specific Aim #2. Specific Aim #3. Specific Aim #4. Evaluate the role of KATP channels in the suppression of glucagon secretion by Zn2+. Determine the relative importance of [unreadable]-cell secretory products, insulin, Zn2+, GABA and ATP, in the suppression of glucagon release. Determine the mechanism of amino acid stimulation of glucagon release from wild-type and Sur1KO islets and identify the [unreadable]-cell transporters and/or pathways involved. Evaluate the relative importance of local vs CNS control of [unreadable]-cell function using mice with targeted deletion of [unreadable]-cell KATP channels.

Public health relevance
Project Narrative/Relevance The complications of diabetes, including nerve damage, blindness, kidney disease, erectile dysfunction and increased risk of heart disease and stroke, are critical public health issues worldwide. Good glycemic control and avoidance of hypoglycemia are keys to delaying these increasingly costly complications. All therapeutic strategies aimed at achieving good glycemic control must address both the failure of β-cells to provide adequate insulin and the inability of α-cells to function correctly in the absence of β-cells. This application is focused on understanding the interplay between ¿- and ¿-cells with the long-term objective of restoring normal glycemic control.